Role of BNIP3 and mitophagy in muscle atrophy and cancer cachexia

Project Summary
The proposed research sets out to examine the role of BNIP3 and mitophagy in muscle atrophy
during cancer cachexia that is prevalent in pancreatic ductal adenocarcinoma (PDAC). Using
physiologically relevant genetically engineered mouse (GEM) models of PDAC, we examine how
BNIP3 promotes atrophy of myofibers with a focus on its role in reducing mitochondrial mass to
levels incompatible with sustained growth and homeostasis of specific myofiber types. We also
examine how reconstitution of myofibers with different mutant forms of BNIP3 affects key
signaling pathways and myofiber growth. We also address the stresses and signals that may
explain induction of BNIP3 in muscle by growing PDAC tumor and if these explain the differential
muscle atrophy seen between males and females. These mechanistic insights are then
interrogated in human PDAC patient muscle samples to determine whether BNIP3 levels in
patient muscle predicts the extent of cachexia and survival outcomes (Aim 1). Separately we
address how muscle atrophy promotes pancreatic tumor growth and progression by examining
how muscle atrophy increases the release of proteins and metabolites into the bloodstream at
early stages of pancreatic cancer that may promote progression of benign PanIN lesions to
PDAC and increased tumor growth. Finally, we examine whether such muscle-derived factors
in the circulation could serve as reliable biomarkers of early-stage pancreatic cancer that will be
important for earlier clinical intervention and longer-term survival outcomes for PDAC patients
(Aim 2).

Public health relevance
Project Narrative Work proposed here will provide novel mechanistic insight to the role of BNIP3 and mitophagy in the debilitating effects of muscle wasting during cachexia associated with pancreatic cancer, and identify novel muscle-derived biomarkers released into the bloodstream due to cachexia that could lead to earlier detection of pancreatic cancer at stages when treatment options are more likely to succeed.